ADMINISTRATIVE CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Specific Aims 1. Pay partial salary for the Program Director/PI, full salary for the Program Administrator, the Program Assistant, the Core Administrator and the Part-time Core Assistant. Also support a portion of the nonpersonnel costs to administer the RCMI program. 2. Provide travel support for Dr. Bond Program Director (PD), Ms. Pinkston, Program Administrator (PA), Mrs. Tookes, Program Assistant (PAsst), Ms. Alexander, Core Administrator and Mrs. Osborn, Core Assistant, to attend Research Administration Organizational meetings. 3. Provide travel support for the External Advisory Committee members. 4. Provide travel support and honoraria for Project Advisors in Activity 7,8 and 9. 5. Faculty development costs for junior faculty/PIs in Activity 8 and 9, and the postdoctoral fellows in Activity 7. 6. Fund an annual Research Symposium at MSM with a different research area specific to our funded research topics. 7. Support development and implementation of a program evaluation plan.